Unintended Consequences: The Impact of VA Antipsychotic Reduction Efforts in Dementia

Background: Given significant concerns about risks and benefits, the VA and the Centers for Medicare and
Medicaid Services (CMS) have each embarked on initiatives to reduce off-label use of antipsychotic
medications (APs) for the nearly universal and burdensome behavioral and psychological symptoms of
dementia (BPSD). The percent of residents on APs in nursing homes (NH; in the VA, Community Living
Centers or CLCs) is used by policymakers as the main quality indicator for BPSD. In addition to NH/CLCs,
policymakers are also concerned with high rates of AP use in community settings. Using VA data from 1999-
2007, we previously found that AP use reductions following the 2005 FDA black box warning (regarding
increased mortality for APs in dementia) were simply offset by increases in use of other classes of
psychotropic medications, with no overall decrease in psychotropic use. Thus, policies focused entirely on
reducing AP use may have caused “unintended consequences,” such as providers shifting patients to
alternative psychotropic classes with even less evidence of benefit and similar risks, including
benzodiazepines, mood stabilizers, and antidepressants. Rather than substituting other psychotropics, multiple
expert bodies recommend the use of behavioral and environmental interventions as the preferred alternative to
APs for BPSD. The VA has widely implemented a program to increase uptake of such interventions within CLC
settings called STAR-VA. However, STAR-VA has to date been implemented in a minority of CLCs, does not
target prescribing, and its sustained impact is unknown.
In partnership with the VA Office of Mental Health Operations, Mental Health Services, the
Psychotropic Drug Safety Initiative, STAR-VA, Geriatrics and Extended Care, and Pharmacy Benefits
Management, this study will examine the system- and facility-level consequences of VA and non-VA
initiatives related to dementia intended to reduce AP prescribing.
Objectives: Aim 1: To determine system-level VA national trends (in both CLC and community settings) in
psychotropic use among patients with dementia since the first black-box warning (2005) to 2014; Aim 2: To
examine CLC-level variables that may be associated with AP prescribing in dementia (FY2014); and Aim 3: To
validate additional quality indicators for VA patients with dementia for both CLC and community settings.
Methods: In Aim 1, using interrupted time-series analyses, VA national health system administrative data (FY
2005-2014) will be used to examine the impact of initiatives to reduce antipsychotic use in dementia, with a
focus on substitution patterns of other psychotropics for antipsychotics. We will also assess variation found in
post-warning changes in AP and other psychotropic use in Veterans with dementia by variables including:
race/ethnicity; academic affiliation; and geographic location. In Aim 2, CLC facilities classified into quintiles by
mean facility-level AP prescribing (in FY 2013) will be compared on variables (derived from FY2014 data) that
may reflect both unintended and desired consequences in quality of care for residents with BPSD, including: 1)
other psychotropic use, physical restraint use, and health care utilization; 2) BPSD level prior to AP
prescription; and 3) an available measure potentially reflecting quality of CLC care and non-pharmacologic
strategy use (the Artifacts of Cultural Change or ACCT) and implementation of STAR-VA (yes/no). Informed by
the findings from Aims 1 and 2 regarding factors that are associated with quality of care for veterans with
dementia, in Aim 3, we will use a two-round modified Delphi panel of experts and stakeholders in dementia
care and BPSD to validate additional, clinically-relevant quality indicators.

Public health relevance
Currently, there are an estimated 268,000 VA patients with dementia. This number will continue to grow to over 335,000 by 2033. Behavioral and psychological symptoms of dementia (BPSD) include agitation, aggression, depression, psychosis, anxiety, sleep problems, and socially and sexually inappropriate behaviors. BPSD are universal, found in all types and stages of dementia. This proposal will benefit those Veterans with BPSD as well as providers and policymakers by helping to understand the impact of current VA initiatives to reduce antipsychotic prescribing in Veterans with dementia, while describing the potential unintended consequences of such efforts. Our findings will generate the data needed to facilitate the introduction of additional, clinically- relevant measures of quality to help improve the care of Veterans with dementia and BPSD.